Integrating Medicare and Medicaid coverage in managed care: effects on quality, utilization, and disparities

PROJECT SUMMARY / ABSTRACT
Policymakers are pursuing strategies to integrate coverage for dual-eligibles—individuals with Medicare and
Medicaid—to better coordinate care across these programs. Dual-Eligible Special Needs Plans (D-SNPs)—
Medicare Advantage plans that exclusively serve duals—have emerged as the largest category of plans
intended to serve as a platform for integration. However, D-SNPs vary in their level of integration with
Medicaid. While many D-SNPs meet only a minimum level of integration (primarily related to care
coordination), a growing number of plans have attained greater integration by covering Medicare and Medicaid
spending for the same patients. CMS continues to refine integration standards for D-SNPs and policymakers
have called for designing these standards to improve the quality, efficiency, and equity of care for duals—a
priority given this population’s medical and social vulnerability. Yet little evidence exists about the extent to
which differences among D-SNPs, including plan attributes and state policies affecting integration, are linked to
quality, care patterns that drive spending, or disparities. Further, there is no evidence about how policy levers
to expand enrollment in integrated D-SNPs affect care. One such lever is default enrollment—a mechanism
that allows certain Medicaid managed care plans to automatically enroll Medicaid beneficiaries into integrated
D-SNPs when they become dual eligibles (e.g., at age 65). Although only some D-SNPs are permitted to use
default enrollment, there is interest in expanding this mechanism. To inform policy, this project will provide new
evidence about variations in the performance of D-SNPs, including by factors affecting these plans’ level of
Medicaid integration (Aim 1); assess plan performance and disparities in vulnerable subgroups of duals,
including Black and Hispanic duals, duals with a disability, and those with behavioral health conditions (Aim 2);
and investigate the effects of using default enrollment to integrate coverage, leveraging variation between
plans permitted to use this mechanism and a quasi-experimental difference-in-differences design (Aim 3). To
measure key aspects of plan performance relevant to integration, we will use Medicaid T-MSIS data, Medicare
Advantage encounter data, and nursing facility assessment data linked at the beneficiary level (Aims 1-3) and
CAHPS patient experience surveys (Aims 1-2). Continuous updating of these data allows us to monitor
changes in performance as CMS phases in new D-SNP integration standards, enabling us to evaluate and
inform evolving policy. This project is directly related to AHRQ priorities and priority populations through its
focus on how the design of D-SNPs—an emerging managed care model for complex patients—affects quality,
efficiency, and equity of care. To maximize this project’s impact, we will work with a Policy Advisory Committee
of experts in integration policy from the government, research, and insurance sectors, building on the team’s
track record of translating health services research to inform policy.

Public health relevance
PROJECT NARRATIVE Dual Eligible Special Needs Plans (D-SNPs) have emerged as the largest category of managed care plans intended to integrate Medicare and Medicaid coverage for the nation’s 12.2 million dual eligibles and have evolved to attain different levels of integration. This project will use national Medicare and Medicaid administrative data, nursing facility assessment data, and patient experience surveys to identify attributes of D- SNPs and state Medicaid policies associated with higher quality, efficient, and equitable care, and it will use a difference-in-differences design to identify effects of integrating coverage, leveraging variation in default enrollment into integrated plans. Findings from this project will provide evidence to guide how policymakers improve D-SNPs to address the health care needs of their medically and socially vulnerable enrollees.